Protein Folding in the Eukaryotic Cytosol

The long term goal of this Research Program is to understand how newly translated
proteins fold in eukaryotic cells. The proposed research will focus on folding events as
they occur at the ribosome during synthesis of a polypeptide and will examine the role of
molecular chaperones in their folding process. The conceptual framework for
understanding de novo protein folding originates from our work in the previous funding
cycle, which showed that a network of chaperones named CLIPS (Chaperones Linked to
Protein Synthesis) is physically and functionally linked to the translation machinery. Our
working hypothesis is that the CLIPS chaperones are tasked with guiding newly
synthesized polypeptides to their folded conformation. Chaperone-mediated folding
pathways appear to involve the cooperation of different classes of CLIPS, including
chaperones that act early in the folding process, such as the Nascent Chain Associated
Complex (NAC), the Hsp70 proteins and the GIM/prefoldin complex, and the
mechanistically distinct chaperone TRiC/CCT, which appears to act later in the folding
process. Our general strategy to elucidate how chaperones mediate the folding of newly
synthesized proteins relies on the close integration of in vitro and in vivo approaches with
computational biology analyses. Our proposed experiments are aimed at obtaining
functional, mechanistic and structural insights into the role of chaperones in de novo
folding.

Public health relevance
Protein folding is a key step in the expression of the genetic information; thus, failure to fold correctly leads to misfolding and aggregation associated with many pathological states. The long term goal of this Research Program is to understand how newly translated proteins fold in eukaryotic cells and elucidate how chaperones mediate the folding of newly synthesized proteins. Our proposed experiments are aimed at obtaining functional, mechanistic and structural insights into the role of chaperones in de novo folding through the close integration of in vitro and in vivo approaches with computational biology analyses.